Novel bi-specific immunoprophylactics against multi-drug resistant Gram-negativebacterial infections

The Centers for Disease Control and Prevention (CDC) estimates that at least two million illnesses and 23,000
deaths annually are caused by antimicrobial-resistant bacteria in the United States. The Gram-negative (G-)
pathogens are of particular concern, as they account for roughly 99,000 deaths and $20B in health care costs a
year. More alarming, treatment options for G- infections have become increasingly limited due to rapid
emergence of multi-drug resistance (MDR) to existing and newly approved antimicrobial agents, highlighting the
need for alternative strategies to prevent MDR G- infections. Thus, an agent that leverages immunological
mechanisms to prevent infection in high risk populations from drug susceptible and MDR strains would
possess a unique advantage in addressing this need. The innovative Cloudbreak™ Antibody Drug
Conjugates (ADCs) platform, developed at Cidara Therapeutics, uses a fundamentally new immune-based
approach to prevent and treat G- infections. Similar to successful cancer bispecific agents, ADCs bind conserved
targets on pathogens via a Targeting Moiety (TM) while simultaneously engaging multiple arms of the immune
system via an Effector Moiety (EM). The TM is comprised of a dimeric peptide that binds tightly to
lipopolysaccharide (LPS) and confers broad spectrum G- coverage with potent intrinsic antimicrobial activity.
The EM is a human IgG1 Fc, which collectively activates complement dependent cytotoxicity (CDC), antibody
(Ab)-dependent cell-mediated cytotoxicity (ADCC), and Ab-dependent cell phagocytosis (ADCP) to clear MDR
G- pathogens from the host, via recognition by Fcγ receptors on host cells.!This innovative approach involving
efficient cell targeting with inherent cell killing catalyzes a robust immune response by more effectively presenting
the pathogen to immune components for clearance. CTC-026 is our lead ADC candidate and has demonstrated
highly promising properties as an immunoprophylactic agent: broad spectrum antibacterial activity that is both
intrinsic and immune-driven, acute safety in rodents, in vivo efficacy in mouse models of Escherichia coli sepsis
and Acinetobacter baumannii pneumonia, and a 67 hour plasma half-life in mice. Further optimization of potency
and spectrum and in-depth evaluation of pharmacological and toxicological properties of this lead are proposed
in this application. The overarching goal of this proposal is to identify a qualified lead development candidate
in Year 3 and an Investigational new drug (IND) candidate by the end of Year 5, that meets these criteria: 1)
acceptable stability and solubility for IV formulation, 2) MIC90s ≤1 µM against clinical isolates (including MDR) of
Klebsiella, Acinetobacter, Pseudomonas and E. coli, 3) MIC90s ≤1 µM against MCR-1, MCR-2 and other colistin-
resistant G- clinical isolates, 4) robust in vivo prophylactic efficacy against MDR G- infections in a time window
48-72h prior to infection, 5) PK/PD parameters to support once weekly or better dosing in humans, 6) a NOAEL
in GLP toxicology studies in rats and Cynomolgus monkeys at least fivefold higher than the targeted clinical
dose, and 7) a scalable synthesis to GMP product.

Public health relevance
PROJECT NARRATIVE Gram-negative bacterial pathogens Escherichia coli, Klebsiella pneumoniae, Pseudomonas aeruginosa, Acinetobacter baumannii and Enterobacter species are associated with life- threatening systemic infections which pose an enormous burden to the public health system. Their ability to rapidly develop drug resistance and propagate as multi-drug resistant, and now pan-resistant pathogens, begs the need for new agents that leverage immunological mechanisms to prevent infection in high risk populations. In an effort to meet this challenge, we propose to develop a novel immunoprophylactic agent as a highly effective countermeasure against this increasingly serious public health threat.